The Molecular Signatures Database: A knowledgebase for gene set based analysis of genomic data

Project Abstract
The Molecular Signatures Database (MSigDB) knowledgebase, which we introduced almost 20 years ago, is an
open access resource of well annotated Human and Mouse gene sets. It is used with multiple gene set based
genomic analysis methods to elucidate the biological mechanisms associated with disease and other biological
phenotypes, generating hypotheses for further study and experimental validation. As of January 2024, MSigDB
provides over 50,000 expertly annotated sets of genes that share common biological function or regulation.
MSigDB’s support of a pathway- and biological process-centric view of data analysis has a history of biomedical
impact significantly contributing to the study of important questions in biology and medicine across many
domains. The impact and popularity of MSigDB are evidenced by its large citation count (>34,000 citations in
Web of Science); its continually growing user community (>350,000 registered users from >70 countries
worldwide); and its highly used portal (hundreds of thousands of page hits per week). We derive the gene
sets in multiple ways: through manual curation of results in scientific publications; computational analysis of
publicly available transcriptomic data sets; and mining and curating of public pathway and ontology
databases and other public resources. The sets are provided in multiple gene identifier namespaces, using the
latest versions of standards established by community-recognized authorities. They are continually reviewed
and updated. As we continue to grow the knowledgebase, we prioritize thoughtful selection of new sources and
development of gene sets with careful and expert annotation. The sets are available both as investigator-
friendly gene set webpages which include information on the origin of the set and biological annotation, as
well as machine readable forms for use by software developers and bioinformaticians for programmatic
access, testing of new methods, and inclusion in other resources. The interdisciplinary MSigDB team includes
computational and genomic scientists, a scientist curator with a PhD in biology, computer science experts
in natural language processing, and experienced software engineers. We seek funding of MSigDB for the
next five years to continue our support of the large community of biomedical investigators who depend on it
for their work. We will: 1) continue to thoughtfully expand the content of MSigDB and keep it up to date with
semiannual releases; 2) enhance and optimize the MSigDB build and quality assurance process; 3) explore
the use of large language models (LLMs) to assist in gene set annotation; 4) perform a major update of the
MSigDB portal architecture and implementation; 5) enhance the MSigDB tools for gene set exploration; 6)
continue our high-value user support and increase community engagement.

Public health relevance
Project Narrative Gene set based analysis is now standard practice for interpreting genome-wide expression data and elucidating the biological mechanisms associated with disease or other cellular states. The approach requires the use of a well-annotated knowledgebase of gene sets representing biological processes, pathways, phenotypes, and cellular perturbations, and the Molecular Signatures Database (MSigDB) has provided such a resource since 2005. The work in this project will significantly increase the already high impact of MSigDB’s gene set collections to even better derive hypotheses for further investigation and validation and thereby accelerate and facilitate the study of important questions in biomedical research.